Whole Eye Optical Coherence Tomography to Improve Eye Care

ABSTRACT
This research proposal from a multi-disciplinary team including ophthalmologists and biomedical engineers
seeks to improve the imaging and characterization of posterior eye deformities such as in progressive or
pathologic myopic and high intracranial pressure. The three-dimensional changes seen in the posterior eye
with these diseases have usually been characterized using neuro-imaging. To make this assessment more
available in the clinical ophthalmic setting, we will further develop our “whole eye” optical coherence
tomography (OCT) system specifically for this application. This OCT system will have hardware and software
innovations to quantitatively assess the three-dimensional deformation of the posterior eye in these diseases.
With these data, we can identify shape metrics which can help to distinguish pathologic from “regular” high
myopia, progressive from non-progressive myopia, and for high intracranial pressure, we will assess the
evolution of the eye deformation in the posterior eye over the patient’s care.
These developments have both direct immediate clinical and research applicability by providing imaging
biomarkers to characterize posterior eye deformation. In addition, given that a whole eye OCT system will be
deployed to a second site, there will be a demonstration of the applicability of this technology outside the origin
laboratory.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it is expected to improve the ability of eye care providers to better assess the three-dimensional changes in the posterior eye that result from changes in progressive and pathologic myopia or high intracranial pressure, all potentially visually disabling diseases. Leveraging innovative imaging technologies developed by our laboratories and specifically designed analysis of posterior eye shape, we expect to provide quantitative information about these posterior eye deformations to support clinical care and research into the anatomical changes involved in these diseases.